Offsetting CNS inflammatory damage with anti-CXCR3 antibody immunotherapy

Cryptococcus neoformans: is an environmental fungal pathogen that causes substantial morbidity and
mortality worldwide, recently named among 4 critically important fungal pathogens on the WHO global priority
list. Veterans are at increased risk of cryptococcosis due to higher-than-average rates of conditions associated
with immune compromise. The CDC estimates nearly 200,000 deaths per year are attributable to C.n. infection
with almost all related to cryptococcal dissemination to the central nervous system CNS, resulting in fatal
cryptococcal meningoencephalitis (CM). The survivors frequently develop disabilities due to CNS damage.
There is increasing evidence these paradoxical responses to therapy are mediated by patients own immune
response to the fungus, further supported by the beneficial effects of anti-inflammatory therapy. We reported
that CXCR3+,Th1 T-cells represent a pathological cell subset that is dispensable for clearance of CM and
propose that interception of CXCR3-pathway with anti-CXCR3 antibody (Ab) therapy will create a “protective
shield” for neurons and significantly reduce the inflammatory damage in patients with fungal and possibly other
types of CNS infections known to trigger the inflammatory CNS damage. Our preliminary data support highly
beneficial role of anti-CXCR3-Ab therapy in mouse model of CM but these novel findings need to be validated
before anti-CXCR3-Ab can be considered for clinical trials. Our goal is to validate that to demonstrate pre-
clinically that this therapeutic strategy could be a viable option for the treatment/ prevention of inflammatory
CNS injury that occurs during CNS infections. The proposed 2-year project will assess and validate beneficial
effects of anti-CXCR3 antibody therapy in using 3 mouse models of CM that show different scope of fungal
virulence or inflammatory response, alone, and in the settings of standard antifungal therapy used in patients
with CM.
Aim 1: To validate effects of anti-CXCR3 antibody treatment on the development of CNS symptoms
and inflammatory pathology in models of models of murine CM.
a) To evaluate benefits of anti-CXCR3 treatment in a highly inflammatory model of mouse CM with strain
52D.
b) To evaluate effects anti-CXCR3 treatment in a balanced inflammation model of mouse CM with strain
184A
c) To evaluate effects of anti-CXCR3 treatment in progressive model of mouse CM with strain H99
Aim 2: To validate effects of anti-CXCR3 antibody treatment in combination with standard of care anti-
cryptococcal drug therapy. The inflammatory brain injury can occur despite the standard treatment with
antifungal drugs in both human patients and in our mouse model. These studies will determine if beneficial
effects of CXCR3-neutralization would be synergized when combined with antifungal therapy using following
approaches:
a) To evaluate benefits of anti-CXCR3 therapy in CM models with strains 52D, 184A, and H99 in
combination with the liposomal Amphotericin B.
b) To evaluate benefits of anti-CXCR3 therapy in CM models with strains 52D, 184A, and H99 in
combination with fluconazole
The proposed validation of therapy targeting CXCR3 will intercept a specific pathway of CNS injury directly
involved in the “CNS-damage cascade”. It will create much safer alternative to the long-term treatment with
high doses of corticosteroids, which at this time is the only known intervention in patients developing
inflammatory brain injury in response to CNS infections. This addresses an unmet need for targeted
immunotherapies that could reduce “collateral” immune damage within the infected CNS.

Public health relevance
Cryptococcus is a ubiquitous fungal pathogen that causes substantial morbidity and mortality in Veterans and other patients. Veterans have an increased risk of infection due to higher rates of immunocompromising medical conditions relative to the general population. Current therapies for patients infected with Cryptococcus are lengthy, highly toxic, often ineffective, and may contribute to inflammatory complications linked to pathological tissue damage, mortality, and/or the development of lasting disabilities in these patients. Antibody immunotherapies neutralizing targeted pathways already have revolutionized the treatment of autoimmune diseases and some types of leukemia, through their specificity allowing for the elimination of a single immune factor which has a causal role. This validation study will test the effectiveness of anti-CXCR3 antibody treatment in limiting detrimental immune responses during cryptococcal CNS infection using a mouse model of cryptococcal meningitis and promises to create much safer alternative to the existing treatment.